Multimodal Artificial Intelligence to Predict Glaucomatous Progression and Surgical Intervention

Project Summary
The overall objective of this proposal, “Multimodal Artificial Intelligence to Predict Glaucomatous Progression
and Surgical Intervention”, is to use multimodal artificial intelligence (AI) and deep learning strategies to predict
which glaucoma patients will need glaucoma surgery and which are likely to have progressive visual field loss
in the future. This study is designed to leverage longstanding well characterized clinical and research cohorts
of glaucoma patients and its validated decision support AI infrastructure to predict which glaucoma patients will
progress and which will need surgery. The proposal includes the following two Specific Aims. Aim 1 will use
baseline electronic health records (EHR), optic nerve head (ONH) optical coherence tomography (OCT)
imaging, visual field (VF) data, intraocular pressure (IOP) and central corneal thickness (CCT) in a multimodal
DL model to predict the likelihood of surgical intervention for glaucoma. Aim 2 will use baseline EHR, ONH
OCT imaging, VF data, IOP and CCT in a multimodal DL model to predict the likelihood of fast glaucomatous
visual field progression. To address these aims, existing data from glaucoma patients 1) enrolled in the
National Eye Institute funded Diagnostic Innovations in Glaucoma Study (DIGS 1995-present) and African
Descent and Glaucoma Evaluation Study (ADAGES 2009-2021), and 2) managed at the UCSD Viterbi Family
Department of Ophthalmology will be used in the AI model development and testing. We will also leverage
UCSD's existing cloud-based AI pipeline to build a glaucoma-specific platform to train, test and in the future,
update the deep learning models developed. In the future, this infrastructure can be used to support
randomized clinical trial testing of AI guided glaucoma management and enable real-time decision support for
clinicians.

Public health relevance
Narrative Innovations in artificial intelligence (AI) algorithms have exponentially increased with the widespread digitization of healthcare data in general and ophthalmic data in particular. However, the implementation of AI- based technologies into clinical ophthalmic practice for clinical decision support is still in relatively early stages. This study is designed to leverage well characterized clinical and research cohorts of glaucoma patients and its validated decision support AI infrastructure to predict which glaucoma patients will progress and which will need surgery. Specifically, we will develop deep learning algorithms to predict 1) patients who will need glaucoma surgery and 2) patients who are progressing in the next 12 months, and 2 years. We will leverage data from diverse research and clinical glaucoma populations for the development and testing of the deep learning models. These algorithms can then be used to support randomized clinical trial testing of AI guided glaucoma management using the AI models developed.